Investigating the landscape and genetic architecture of germline mutagenesis

PROJECT SUMMARY
The rate at which DNA mutates ultimately determines how many people are born with serious genetic dis-
eases, as well as how long a person is likely to live before getting cancer. It is also crucial to understand how
mutations generate genetic variation in order to accurately infer evolutionary history from genomic data. Despite
this fundamental importance for human health and disease, we know little about how the mutation rate varies
from person to person and what genetic factors might cause the mutation rate to vary. My previous research has
shown that mutations from different populations are biased to occur in different sequence contexts; for example,
Europeans contain more mutations in the motif “TCC” than Africans or East Asians do. This implies that each
population is affected by a distinctive combination of sequence-biased mutational processes. Unless these dif-
ferences are all induced by environmental mutagens, some of them must be the signatures of “mutator alleles,”
genetic variants that subtly affect the likelihood of DNA damage or the efﬁcacy of DNA repair. This proposal
describes a multi-pronged strategy for interrogating the causes and consequences of variation in DNA replication
ﬁdelity. The ﬁrst step will be to look beyond short, three-letter motifs to identify longer DNA sequences that differ in
mutability between populations. To achieve this, we will adapt statistical techniques that have recently been used
to identify the motifs that drive hypermutation in immune cells. Once we identify such motifs, we will scan them for
concordance with the rich libraries of motifs that are known to regulate protein binding and gene expression. For
the ﬁrst time, we propose to incorporate ancient DNA into our analyses of human mutation spectrum variation,
aiming to improve our understanding of the pace of mutation rate evolution and interrogate the role of global mi-
gration events in spreading mutator alleles. As a complement to this work on humans, we will also study mutation
sequence context variation in polar bears and brown bears, which have been hybridizing for thousands of years
in a unidirectional way with polar bear migrants entering the brown bear population but never the reverse. By
analyzing the covariance of mutational sequence context in polar bears and brown bears across a range of allele
ages, we will infer how often mutator alleles have crossed from one species to another. In natural populations,
is difﬁcult to map the genomic locations of mutator alleles because they are predicted to quickly recombine away
from mutations they create; to overcome this difﬁculty, we are working with collaborators to study mutagenesis
in model organisms, where inbreeding can be used to force mutations to stay linked to the genetic backgrounds
on which they arise. We will develop methods to map mutator alleles in two different inbred model systems: the
BXD recombinant inbred mouse strains and the Drosophila Genome Reference Panel, looking for regions of the
genome where speciﬁc genetic variants are associated with mutability in speciﬁc sequence contexts. Together,
these lines of research will generate a fuller picture of mutagenesis as a quantitative trait that varies between
populations and evolves over time.

Public health relevance
PROJECT NARRATIVE All genetic diseases, cancers, and evolutionary innovations ultimately begin with genetic mutations. Despite this fundamental role that mutagenesis plays in human health, we know very little about the genetic factors that might cause some individuals to transmit more mutations to their offspring than others. Recently, we discovered that humans from different populations tend to transmit different types of mutations to their offspring, and we are investigating how these different types of mutations differ with regard to their causes and their health effects.